Component B:Review of Oral Health Interventions for People with Intellectual Disa

DESCRIPTION (provided by applicant): Researchers from the University of Massachusetts Medical School (UMMS) will partner with the American Academy of Developmental Medicine and Dentistry (AADMD) to complete a systematic review of interventions that aim to reduce disparities in oral health in the population with intellectual disability. National and internationl research has demonstrated that people with intellectual disability are at greater risk of experiencing untreated tooth decay and other oral health complications that can negatively impact their general health and wellness. Barriers to oral health care include policy and financial constraints and a lack of trained clinicians that limit access to necessary care, and factors related to health behaviors such as personal factors limiting the ability to tolerate dental procedures, and attitudes that minimize the importance of oral health among care providers. Interventions have been developed to address both access and oral health issues but have not been systematically studied. Using a formal protocol, an advisory committee an expert review panel, and an expert consensus panel, the research team will identify and review a wide range of interventions for their effectiveness to improve the oral health in this population.

Public health relevance
Project Narrative This project will develop the evidence base for interventions that improve oral health in the population with intellectual disability (ID). National and international research has shown that people with ID are more likely to have untreated tooth pain and decay, and to be at risk for health problems associated with poor oral health. The researchers will complete a systematic review of programs, policies, and procedures that aim to improve access to oral health care, and promote good oral health behaviors such as tooth brushing. The results of the systematic review will be compiled and presented publicly to help guide clinicians and policy makers to expand effective ways to improve the oral health of this population. __SpecificAimsTextDelimiter__ Specific Aims Oral health is one of the foremost areas of public health need for people with an intellectual or developmental disability (I/DD). The Surgeon General"s 2002 report: Closing the Gap, a National Blueprint to Improve the Health of Persons with Mental Retardation1 focused national attention on the health disparities in this population and identified oral health as a priority area for action. Ten years later, the call to action is still relevant and necessary. A 2010 review of oral health in people with I/DD found consistent evidence of poorer oral hygiene and higher prevalence and greater severity of periodontal disease, as well as a higher incidence of untreated caries in this population compared to the general population.2 In its athlete screening program, Special Olympics reports that 39% of the athletes screened have visible, obvious, untreated dental decay.3 Poor oral health can cause chronic pain, may severely impact the ability to eat and communicate, and can adversely affect physical health and quality of life. Evidence supports the need for effective strategies for prevention, increased patient acceptance for routine care, and training for dentists and hygienists.2 The purpose of this project is to systematically and rigorously evaluate promising practices with the potential to reduce disparities in oral health for people with I/DD. In partnership with the American Academy of Developmental Medicine and Dentistry (AADMD), the University of Massachusetts Medical School/E.K. Shriver Center (UMMS/Shriver) team will use a systematic review process to evaluate critical success factors associated with programs, policies, or practices that demonstrate evidence of effectiveness in addressing unmet needs and reducing oral health disparity in people with I/DD. Interventions will be reviewed that address both access to oral health care and strategies to improve oral health behaviors. Access to care includes coordination of dental services, availability of specialized equipment, financial incentives to treat, or education and training of health care providers. Health behavior interventions address preventive oral hygiene education and training for people with I/DD, their family, caregivers or support staff, and desensitization techniques. The specific aims of the project are as follows. AIM 1: Frame and refine a formal plan to systematically review interventions targeted at reducing disparities in oral health outcomes for people with intellectual disability. An expert review panel, including individuals with specialized expertise in oral health care delivery for people with I/DD, systematic review, and representatives from stakeholder groups (policy and service delivery) will inform refinement and validation of the proposed logic model (analytic framework) used to guide the systematic review. The resultant formal review plan will clearly define the target population, and will identify key questions for which data will be collected and reviewed, search terms, inclusion/exclusion criteria, sources for identification of interventions, screening processes for identified interventions, and a data collection instrument to be used during the review of interventions targeted in the systematic review. AIM 2: Systematically review evidence of effective interventions to address disparities in oral health for people with intellectual disabilities. Using the formal review plan created in Aim 1, literature will be collected, screened and systematically reviewed by experts guided by the data collection tool. Interventions lacking sufficient evidence of effectiveness will be referred to the expert panel for assignment of a "level of evidence." Review findings will be synthesized to identify effective interventions and catalogue promising interventions with consensus panel review. AIM 3: Translate and disseminate findings of systematic review for use by varied audiences. The results of the systematic review will be formulated into a manuscript targeted to a refereed journal with an audience of public health practitioners and academic researchers that details the framework for the systemic review as well as evidence-based interventions. Findings will be presented at one national conference aimed at clinical and public audiences and one national conference aimed at individuals with I/DD and their families. Additionally, findings of the review will be translated for lay audiences into a print version and an electronically accessible summary of evidence that includes materials in English and Spanish that is linked to websites for professionals, families and self-advocates with I/DD.